A wireless fully-passive miniaturized patient-tailored pacemaker

Summary
Despite major advances in pacemaker technologies during the past decade, current pacemaker systems still
suffer from several critical limitations. Primarily, the need to implant pacemaker leads within cardiac chambers
could lead to a host of complications such as infection, thrombosis, tricuspid valve and ventricular perforation,
along with the complications associated with the extraction of the lead when required. Furthermore, with
traditional pacemakers, the cardiac regions accessible to pacing are restricted to right ventricle (RV, typically at
the apex) and occasionally, coronary sinus distribution in cases of biventricular pacing. RV pacing creates
abnormal left ventricular (LV) contraction, reduced pump function, hypertrophy, ultrastructural abnormalities and
increases risk of atrial fibrillation, ventricular arrhythmias and ultimately heart failure and death. Leadless
pacemakers address the issue associated with intravascular leads, but they remain limited in pacing only the RV
and require placement of a new pacemaker after battery depletion. The recently developed remote ultrasound-
powered wireless LV pacing electrode in conjunction with traditional pacemaker for biventricular pacing is
technically limited by need for an acoustic window free of rib cage and lung on the transmission path to the
electrode and the high density ultrasound drains battery quickly. To overcome the limitations of currently
available pacemakers, we propose to develop the next generation of pacemaker system composed of
wireless, miniaturized, battery-free, radiofrequency (RF) microwave activated sensor/stimulator
electrodes that could be implantable and controlled by a remote pulse generator. In Aim 1, we will pursue
technical development of miniaturized wireless sensor/stimulator electrodes, operating as a stand-alone
platform, and remote pulse generator controller to monitor simulated cardiac signals and provide pacing signals
using Micro-Electro-Mechanical-Systems (MEMS) and RF technologies on an organic phantom model while
testing safety by measuring heat generation and extraneous RF interference. In Aim 2, we will test the wireless
pacemaker system in vitro by measuring signal detection, pacing stimulation and tissue safety on our validated
biomimetic cardiac micro-tissue model, using human induced pluripotent stem cell derived CMs (hiPSCs-CMs),
as well as in vivo using a rodent thoracotomy model. We envision that the proposed innovative wireless
pacemaker system could usher a paradigm shift in pacemaker therapeutics through the ability to pace precise
regions of the heart resulting in more physiologic pacing and optimization of cardiac performance.
!

Public health relevance
Narrative We aim to develop the next generation pacemaker system composed of wireless, miniaturized, battery-free, radiofrequency (RF) microwave activated integrated sensor/stimulator electrodes that could be implanted in targeted cardiac location and controlled by a remote pulse generator. The proposed system improves on currently available pacemaker systems by reducing potential complications and allowing for more physiologic pacing that would increase cardiac performance. We will validate the functionalities of the proposed wireless pacemaker system in vitro by measuring signal detection, pacing stimulation and tissue safety on our biomimetic cardiac micro-tissue model, using human induced pluripotent stem cell derived CMs (hiPSCs-CMs), as well as in vivo using a rodent thoracotomy model.